Molecular mechanisms underlying functional evolution of bioluminescent proteins from haloalkane dehalogenases

Project Summary
Research in evolutionary biochemistry has provided insights into how new enzyme functions evolve through
changes in substrate specificity. However, much less is known about how new catalytic mechanisms evolve.
What molecular mechanisms and processes shape the emergence of new catalytic mechanisms? To what
extent is this evolution repeatable? And how might evolutionary history shape the evolution of new catalytic
mechanisms? Addressing these questions provides a mechanistic understanding how extant enzymes catalyze
diverse chemical reactions, functioning as molecular machines to produce the diversity of life. This research is
often challenging because diverse catalytic mechanisms are usually found across protein superfamilies,
beyond the phylogenetic horizon of what can be reconstructed. Here, I propose to work with Dr. Joseph
Thornton at the University of Chicago to investigate the repeated evolution of a new catalytic mechanism,
monooxygenase-catalyzed light production, in the bioluminescent proteins of octocorals (Cnidaria) and brittle
stars (Echinodermata). This is an especially powerful system, since these bioluminescent proteins repeatedly
evolved in distantly related taxa, each time by recruiting homologous haloalkane dehalogenases with ancestral
hydrolase activity. A mechanistic understanding of how these bioluminescent proteins repeatedly evolved may
provide fundamental information useful for bioengineering these proteins, which already serve as invaluable
biological tools for reporting gene expression, monitoring protein-protein interactions, and activating molecules
in optogenetics. In this project, I will investigate the molecular mechanisms underlying the repeated functional
transition between hydrolase to monooxygenase activities. First, I will use computational phylogenetic methods
to reconstruct the genetic trajectories to evolving monooxygenase activity for each taxon. Then, I will then use
experimental methods to functionally identify causal mutations between protein sequence and function. Finally,
I will perform manipulative experiments to test the effects of functional mutations at deeper nodes within each
lineage and across lineages. Altogether, these findings will illuminate the molecular mechanisms and factors
underlying the repeated evolution of monooxygenase-catalyzed light production from haloalkane
dehalogenases. More broadly, this research will provide insight into how historical contingency and lineage
specific evolutionary processes shaped the emergence of new catalytic mechanisms. The research training
plan proposed here will prepare me for my future career as an independent principal investigator by
strengthening my expertise in experimental evolutionary biology and computational molecular phylogenetics.
This training will allow me to develop a robust framework in molecular evolution, supporting my integrative and
interdisciplinary research program that combines organismal evolutionary biology with biochemistry to
understand the evolution of novel phenotypes across biological scales.

Public health relevance
Project Narrative Bioluminescent proteins are widely used in biological research as molecular reporters for in vitro gene expression and protein-protein interactions, in vivo biological imaging, and optogenetics. This proposed research aims to uncover the molecular mechanisms underlying the repeated evolution of bioluminescent proteins. More broadly, this research will provide a fundamental understanding of how new catalytic chemistries originate during protein evolution.